DECONVOLUTION OF LH, FSH AND PROLACTIN IN NORMAL CYCLING WOMEN

The investigators will use deconvolution of the secretory impulse to evaluate the pulsatile secretion of LH, FSH and PRL during the normal menstrual cycle.